Clinically Meaningful PTSD Improvement: Reducing Risk for Adverse Outcomes in Comorbid Cardiometabolic Disease

Posttraumatic stress disorder (PTSD) is the 4th most common, non-substance related, psychiatric disorder in
the United States. Patients with PTSD vs. those without have a significantly greater risk for type 2 diabetes
(T2D) and cardiovascular disease (CVD) and mortality. Determining if PTSD improvement is associated with
addresses NHLBI priorities and informs efforts to reduce health
disparities related to psychiatric disorders. But even in patients who experience improvement, residual PTSD
symptoms may contribute to adverse T2D/CVD outcomes. Thus, it is important to determine which PTSD
symptoms or combination of symptoms are most strongly associated with adverse T2D/CVD outcomes in
patients with comorbid PTSD and T2D or CVD.
better T2D/CVD outcomes and lower mortality
This proposal builds on our past 4-years of funded research
We now move our
focus away from incident T2D/CVD to outcomes in comorbid PTSD and T2D/CVD. There are no studies that
have determined if patients with comorbid PTSD and T2D or CVD who do vs. do not have clinically meaningful
PTSD improvement are at lower risk for adverse T2D/CVD outcomes and death. There are no studies which
have determined if specific PTSD symptoms (e.g., hyperarousal) or combination of symptoms are associated
with adverse T2D/CVD outcomes and mortality. Our design determines if PTSD improvement is followed by
better T2D/CVD outcomes and whether this is mediated by disease management variables such as medication
adherence.
focused on PTSD treatment and improved health behaviors, and incident T2D and CVD.
We do not study a specific type of PTSD therapy because we want to demonstrate whether PTSD
is a modifiable risk factor for T2D/CVD adverse outcomes and mortality. As in the prior funding period, we use
Department of Veterans Affairs’ medical record data. This is an ideal ‘laboratory’ to test our hypotheses. In a
10 year observation period (2012-2022) we will sample 15,193 patients with PTSD and comorbid T2D and
17,442 patients with PTSD and comorbid CVD. Our aims are 1) determine if separate PTSD phenotypes
(derived from latent class analysis of PTSD symptoms), and symptom change, in patients with comorbid PTSD-
T2D/CVD, are differentially associated with an increased risk for adverse T2D and CVD outcomes, including
disease related and all-cause mortality, 2) determine whether risks for adverse T2D and CVD outcomes, all-
cause and cause specific mortality are lower in patients with vs. without a clinically meaningful PTSD
improvement
; 3) determine if measures of T2D/CVD management, such as good glycemic control, statin
medication adherence and improved depression, mediate the association between clinically meaningful PTSD
improvement and T2D/ CVD outcomes.
and 4) conduct planned age, gender, and race sub-group
comparisons. Decades of research on depression and T2D/CVD led to guidelines that acknowledge
depression as a risk factor for poor CVD outcomes. Positive results and confirmatory studies may eventually
lead to similar guidelines that advise providers to screen and treat PTSD to improve T2D/CVD outcomes.

Public health relevance
This study will determine if specific PTSD symptoms have varying associations with adverse T2D and CVD outcomes, including mortality, in patients with comorbid PTSD and T2D/CVD . We will determine if large, clinically meaningful PTSD improvement is associated with a lower risk for adverse T2D and CVD outcomes and test whether measures of T2D/CVD disease management mediate the association between PTSD improvement and adverse outcomes . We expect our results will eventually lead to T2D and CVD treatment guidelines that incorporate treatment of PTSD as a component of T2D/CVD disease management.